When actin’s not actin like actin: Nuclear actin impacts transcription and aging

Project Summary
The functional significance of actin in cellular health and fitness is unquestionable, as the actin
cytoskeleton is required for a diverse array of cellular processes as simple as movement and motility. The loss
of function of actin is seen in clinical manifestations in many diseases, and specifically during the aging process.
However, these studies are limited to the cytoplasm, despite actin being identified in the nucleus over 50 years
ago. The lack of studies of nuclear actin during aging is likely owning to the poorly understood mechanistic
function and the available tools to study nuclear actin. In fact, even studies of cytoplasmic actin during aging is
still a burgeoning field, making the studies of nuclear actin even more elusive. This highly innovative proposal
aims to tackle this major black hole in the field, leveraging our expertise in cytoplasmic actin to shift our research
direction into studying nuclear actin in DNA repair and transcriptional regulation.
Our first goal is to synthesize a robust method to visualize the quality, function, and dynamics of nuclear
actin during stress and aging in C. elegans. As a new field, there are still no existing tools to reliably study nuclear
actin in perhaps the most powerful genetic model organism for aging research. Therefore, we propose to
synthesize multiple methods to reliably stain the numerous variants of nuclear actin. Furthermore, we will
leverage diverse genetic methods to directly study how changes to nuclear actin stability, function, and dynamics
can impact the aging process. We hypothesize that nuclear actin dysfunction during aging contributes to
physiological consequences and perturbing nuclear actin can result in premature aging.
Emerging studies have implicated nuclear actin in DNA and RNA regulation, quality control, and function,
which is unsurprising considering the contents of the nucleus. Here, we aim to study the hypothesis that nuclear
actin can influence DNA repair. Specifically, we hypothesize that nuclear actin filaments form under stress to
recruit DNA repair machinery, and breakdown of this process is what leads to genomic instability and decline of
organismal health during aging. As an alternative hypothesis, we also propose that nuclear actin may play an
important role in transcriptional fidelity. Like DNA integrity, transcriptional fidelity is important to prevent the
synthesis of mutated proteins that can aggregate and cause physiological consequences during aging. Thus,
we argue that nuclear actin can drive protein homeostasis by preventing transcriptional errors, and the
breakdown of this functional process during aging can result in age-related disease.
In this diversity supplement, we focus on the study of nuclear actin’s cell-type specific roles and how this
can impact the aging process. We use a diverse set of methods in C. elegans and mammalian cell culture to
maximize the trainee, Dr. Gilberto Garcia’s scientific training. We pair this with a thorough career development
and training plan that includes mentorship in educational pedagogy, academic teaching, DEI service, and
transitioning into a faculty position at a primarily undergraduate institution.

Public health relevance
Project Narrative The actin cytoskeleton has been historically studied for its functional role in the cytoplasm, although its existence in the nucleus has been identified over 50 years ago. In this proposal, we aim to study the elusive nuclear actin in multiple fields that it has never been explored before: understanding its function and consequences of its breakdown during aging, investigating how nuclear actin regulation changes during stress, and investigating the impact of nuclear actin on DNA repair and transcriptional regulation. In this administrative supplement, we focus primarily on nuclear actin function in a cell-type specific manner, having a combination of C. elegans and mammalian cell culture experiments to maximize training potential for Dr. Gilberto Garcia.